Structural Dynamics at LCLS

ABSTRACT: DRIVING BIOMEDICAL PROJECTS PORTFOLIO
Nine Driving Biomedical Projects (DBP) are selected in this component of the proposed BTRR.
These DBPs were selected based on high scientific merit as well as their need for X-ray methods
to obtain structural and dynamic information that will reveal the detailed function of various
biomolecules of interest. As such, they fulfil the primary purpose of providing scientific context
and motivation for the technologies to be developed by the proposed BTRR. The DBPs will also
provide necessary test beds for the developed technologies and create a virtuous cycle of iterative
technology development that will lead to new broadly available capabilities for the biomedical
community.
The DBPs are organized along three themes. 1-Structure determination of large macromolecules
and membrane proteins. 2-The determination of accurate active site structures of
metalloenzymes, such as ribonucleotide reductase and cytochrome c oxidase, and complex
macromolecular machines, such as RNA polymerase-II. 3-A common research area of all DBPs
involve time-resolved (TR) studies that include research to follow dynamic processes involved in
adenine riboswitch signaling, the transport mechanism of N. gonorrhoeae MtrF, antibiotic binding
to β-lactamase and examination of interaction specificity of CypA variants.
These DBPs will drive method developments in efficient structure determination using the Linac
Coherent Light Source (LCLS). They will also drive the development of robust rapid mixing
capabilities that will reveal antibiotic binding dynamics or enzymatic reactions with high spatial
and temporal resolution, as well as new methods in light activated caged compound release and
understanding conformational space dynamics in biomolecules using light to push them out of
equilibrium.
Overall, the proposed DBPs cover a breadth of scientific problems of high interest to the
biomedical community and NIH and they represent a strong set of requirements that will push the
BTRR technologies towards tools that will serve the biomedical community for the long term.

Public health relevance
NARRATIVE: DRIVING BIOMEDICAL PROJECTS PORTFOLIO A narrative is not required for this component of the proposal.